BEAMMAP: ULTRA-HIGH RESOLUTION TOPOLOGICAL AND CHEMICAL IMAGING WITH SYNERG

PROJECT SUMMARY
The proposed project aims to develop a unique new instrument for multi-mode imaging of biological
samples with sub-cellular spatial resolution. It is enabled by a synergistic combination of Scanning Electron
Microscopy and a new mode of Desorption Electrospray Ionization (DESI) imaging mass spectrometry. The
new technology is called BeamMap for Beam Enabled Accurate Mapping & Molecular Analyte Profiling –
where the enabling beams are the electron beam and the sprayed electrified liquid beam. BeamMap will
provide untargeted characterization of protein, metabolite and lipid chemistry and correlation with topological
features, yielding an order of magnitude improvement in the achievable resolution for electrospray based
imaging, with chemical imaging resolution of ~ 250 nm and electron microscopy topological resolution of ~ 50
nm. Success in this high impact project has potential to bring about a transformative effect on many areas of
biomedical sciences.
The research team will develop, optimize and demonstrate BeamMap using a multifaceted approach that
combines instrument design and simulation of critical components, state of the art micro/nanofabrication, and
validation through carefully controlled experiments. As a result of this work, the research team will have be
developed a fully functional, optimized, and well characterized prototype instrument, ready for application to
challenging biomedical research questions. The PI and his research team are well situated for success, with a
track record of high impact interdisciplinary research in mass spectrometry ion sources, bio-analytical devices,
micro and nano-fabrication, and sensors development.
This research will provide a new enabling technology for research endeavors in fundamental and clinical
biology, medicine, analytical chemistry, and bioengineering. We expect that BeamMap will assume an
important role in biological research as a hypothesis generator, and will become a key tool in molecular
medicine applications. The proposed work will enhance the infrastructure for research and education by
introducing a new powerful chemical imaging tool for use in high impact biological and therapeutic applications
through the Marcus Center of Therapeutic Cell Characterization and Manufacturing
(https://cellmanufacturing.gatech.edu/). Broad dissemination to enhance scientific and technological
understanding will be achieved through technical papers and presentations in scientific forums and the use of
the BeamMap by external scientists.

Public health relevance
PROJECT NARRATIVE The proposed BeamMap multimodal imaging system will enable topological and chemical imaging of biological samples with sub-micrometric resolution. Successful results have the potential for transformational benefits to a wide range of biomedical science applications, including biomarker discovery and improved understanding of healthy and diseased cell biology. BeamMap will provide untargeted characterization of protein, metabolite and lipid chemistry and correlation with topological features, yielding an order of magnitude improvement in the achievable resolution for electrospray based imaging, with chemical imaging resolution of ~ 250 nm and electron microscopy topological resolution of ~ 50 nm.